Neglect, Poverty and Family Services: A Longitudinal Perspective on Child Well Being

Project Summary
Neglect is the most common form of child maltreatment, comprising approximately 75% of child protection
cases, yet is understudied compared to other forms of abuse. Chronic adversities, such as neglect, activate
stress hormones and biological processes that result in a variety of negative effects on the body that are
evident in very young children. While it is clear that there are negative effects of neglect, less understood is the
impact on child wellbeing over time. Additionally, it is well-established that neglect is closely associated with
poverty, yet there has been little examination of the interactions between these two variables over time.
Moreover, it is unclear how effective social services are at preventing future neglect. This study will utilize data
from the LONGSCAN study, a prospective study on child maltreatment, to examine the longitudinal effects of
neglect (specifically the dimensions of failure to provide and lack of supervision) and its co-occurrence with
poverty. The LONGSCAN consortium is a collaboration between five study sites intended to examine child
maltreatment from ages 0-16 with common measures and methodologies and frequent assessments. The
sample contains variability in the experiences of neglect and poverty, allowing comparisons across different
exposures. In the first aim, competing hypotheses will be examined concerning how neglect imparts harm,
assessed using measures of mental health and social/emotional adjustment. One hypothesis is that there may
be a critical period where experiences of neglect are particularly deleterious. Alternatively, chronic experiences
of neglect may result in a cumulative effect – the more ongoing experiences of neglect, the more severe the
sequelae. It is predicted that there is a critical period for neglect in early childhood. A series of nested models
will be performed to test these hypotheses regarding critical periods and cumulative effects, controlling for race
and gender. The models will be re-estimated controlling for demographics, poverty, other forms of
maltreatment, and geographical study site within the LONGSCAN data. In the second aim, latent transition
analysis will be used to detect patterns of co-occurrence of the two neglect subtypes and poverty across four
developmental periods from 0-16, and will identify the transition probabilities between derived statuses at the
subsequent developmental period. The effects of service, classified as one of three service types (poverty,
neglect, and other services), will then be examined to determine if they effectively change the probability of
subsequent poverty and neglect. The hypothesis is that for those who experience both poverty and neglect,
services that address neglect will be most effective in conjunction with poverty services. The knowledge gained
from this study can inform decisions about how best to respond to neglect during differing developmental
periods. Furthermore, by understanding the frequency with which poverty and neglect co-occur, and whether
certain services can change those outcomes, practitioners can better disrupt chronic and persistent trauma
and contribute to improved child wellbeing.

Public health relevance
Project Narrative Child neglect is the most common form of child maltreatment and is often intertwined with poverty. This study will utilize the LONGSCAN data to test competing hypotheses about how neglect harms children's wellbeing across development (0-16). Next, this study proposes to examine the co-occurrence of neglect with poverty across childhood and to identify the service types that reduce the likelihood of future reports of neglect. Knowledge from this study will inform child welfare policy about intervening in neglect and has the potential to shift practice paradigms to view poverty as a core aspect of child maltreatment.